ORAL PAMIDRONATE (APD) VS. PLACEBO IN TREATMENT OF POSTMENOPAUSAL OSTEOPOROSIS

To determine the safety, tolerability and effectiveness of continuous oral APD vs. cyclical oral APD vs. placebo on bone density as measured by dual energy x-ray absorptiometry in women with postmenopausal osteoporosis.